Aim32, a multi-faceted redox protein, in mitochondrial biogenesis

PROJECT SUMMARY
Mitochondria are responsible for cellular respiration via the oxidative phosphorylation system (OXPHOS).
They are also centers of cellular redox chemistry because respiration is made up of a series of electron transfer
reactions. Even though the mitochondrial DNA encodes essential OXPHOS components, the vast majority of the
structural subunits and additional bioenergetics factors are encoded in the nucleus, translated in the cytoplasm
and utilize sophisticated import machineries (aka translocons) to reach their final destinations. An important and
large pool of proteins within the mitochondrial proteome are thiols; cysteine (Cys) containing proteins that perform
key functions of protein import and OXPHOS biogenesis and highly relevant in the pathology of a spectrum of
diseases. Redox (reduction-oxidation) regulation of these Cys proteins is thus relevant to their protein activity and
highly significant for overall mitochondrial function. Thioredoxins are well known to play a role in redox regulation
by reducing disulfide bonds in oxidized proteins in order to restore function. Our central hypothesis is that Aim32,
a thioredoxin-like [2Fe-2S] ferredoxin mitochondrial protein that belongs to the thioredoxin-superfamily and
localizes to the matrix and Inter membrane space (IMS), has an underlying role in the redox regulation of Cys
proteins with consequential impacts on OXPHOS biogenesis and protein import, specifically the TIM22 import
machinery. However, how these potential substrates of Aim32 are regulated represents a critical barrier to
advancing our understanding of how thiol redox modifications allow for rapid adjustment of mitochondrial protein
function and overall biogenesis. Furthermore, the identification of pathological variants in subunits of the TIM22
complex and OXPHOS that are implicated in several diseases causing mitochondrial myopathy, makes it
imperative to understand mechanisms that regulate OXPHOS and TIM22 biogenesis.
Using the budding yeast, Saccharomyces cerevisiae as a model system, the goal of this undergraduate-
driven proposal is to evaluate our hypothesis by pursuing three specific aims: 1) Delineate Aim32-mediated
mechanisms underlying TIM22 translocon assembly/stability; 2) Identify role of Aim32 in OXPHOS biogenesis;
and 3) Determine functional relevance of Aim32 in the IMS and matrix. The proposed work is innovative because
we seek to investigate how Aim32 mechanistically regulates TIM22 complex assembly (biogenesis) and
bioenergetics (OXPHOS); two fundamental mitochondrial processes that span the mitochondrial IMS and matrix.
Additionally, allocating specific functions to Aim32 within these sub-compartments, is equally important. The
contribution of this work will be significant in that physiological ramifications of these new-founded roles for Aim32
to mitochondrial and cellular function have not been explored and will be clarified. This research will have a broad
impact on public health because these mechanistic studies will provide key insights into how defects in
mitochondrial biogenesis lead to disease.

Public health relevance
Project Narrative This proposal is relevant to human health because it seeks to elucidate mechanisms of how key processes of protein import and bioenergetics in the mitochondrion are regulated in the yeast model system, and conserved in mammals, that will translate into a better understanding of the molecular basis of a subset of mitochondrial diseases. This project is relevant to NIH’s mission and the mission of the NIGMS because it seeks fundamental knowledge about cellular processes that has the potential for development of strategies for the treatment of mitochondrial disorders.